Exploitation of Intrinsic DNA Repair Defects with DNA Damaging Agents in Cancer

Project Summary: Exploitation of Intrinsic DNA Repair Defects with DNA Damaging Agents in Cancer
The lifetime risk of cancer in the U.S. is 1 in 3 and the financial burden of cancer exceeds 100 billion
dollars annually. These figures are predicted to continue increasing as populations continue to age. Alkylating
agents were the first chemotherapies used to treat cancer with the application of nitrogen mustard gas to treat
lymphoma in the 1940s at Yale. Over the last 80 years, many different classes of alkylating agents have been
developed and they remain an integral component of cancer treatment today. Despite their long history and
prevalent clinical usage, knowledge of how alkylating agents damage DNA is still poorly understood due to the
reactive nature of these species. Additionally, cancers often develop exploitable therapeutic vulnerabilities in
DNA repair pathways that enable them to accumulate more mutations and become more aggressive. This
incomplete understanding of alkylators results in the empirical selection of alkylating agents in cancer treatment
regimens rather than selection based on mechanism and underlying cancer biology.
MGMT and ALKBH2/3 are two key direct DNA alkyl damage reversal enzymes responsible for repairing
a variety of alkyl adducts. These enzymes are also commonly deficient in isocitrate dehydrogenase1/2 (IDH1/2)
mutant cancers such as gliomas, colorectal cancers, and hematological malignancies. Understanding how
alkylators damage DNA in the absence of any repair enzymes and how repair enzymes contribute to alkylator
resistance is crucial for the therapeutic advancement of alkylating chemotherapies including a better
understanding of alkylating agents, the development of novel alkylators, and personalized alkylator selection
based on patient tumor DNA repair status. I will test the hypothesis that targeting cancer cells deficient in either
MGMT and/or ALKBH2/3 with the appropriate alkylator will result in enhanced sensitivity because deficiency in
the corresponding DNA repair pathway will lead to unrepairable damage.
I plan to test this hypothesis through two aims. My first aim is to develop a LCMS-based assay to
profile the spectrum of alkylation damage in cell free plasmid DNA and CRISPR/Cas9 generated glioma
models. This aim will answer the question of how alkylators damage DNA by identifying both the species and
quantities of DNA alkylation adducts that form when cell free plasmid DNA and various glioma model cell lines
are treated with a panel of clinically used alkylators. My second aim is to conduct a high-throughput
differential screen for alkylator sensitivity based on DNA repair pathway status. This aim will elucidate the
relationship between known DNA repair pathways and alkylator sensitivity. Ultimately, this work could contribute
to the therapeutic advancement of alkylating chemotherapies including the development of novel alkylators and
personalized alkylator selection based on patient tumor DNA repair status.

Public health relevance
Project Narrative: Cancer cells often harbor intrinsic DNA repair defects that enable them to accumulate additional mutations and become more aggressive, but these same defects could potentially be exploited for therapeutic gain using an appropriate alkylating agent to cause unresolvable DNA damage and enhanced cell death. This proposal aims to understand how alkylating agents damage DNA, and to identify alkylators that preferentially exploit intrinsic DNA repair defects in cancer cells. The results of this study could contribute to a deeper understanding of alkylating agents, the development of novel alkylators, and the personalized selection of alkylators based on patient tumor DNA repair status.